Pre-clinical studies to repurpose FDA-approved adenosine A2A receptor antagonists for lethal rickettsial infection

Abstract
Rickettsial infections caused by obligately intracellular bacteria of the genus Rickettsia (R) are notoriously
difficult to clinically diagnose early because of their nonspecific flu-like signs and symptoms. The delays lead to
missed treatment windows that result in severe morbidity and mortality. It is forecasted that global climate change
will lead to more widespread distribution of rickettsioses. It is crucial to develop therapeutics for severe infections,
particularly for clinically delayed diagnosed cases. We reported cAMP-signaling plays a critical role during fatal
rickettsioses. The adenosine receptors are a class of transmembrane receptors that can stimulate intracellular
cAMP accumulation. The FDA approved A2AR antagonist istradefylline (Istra) for treatment of Parkinson’s
disease in 2019. During project R21AI137785, we examined efficacies of Istra in mouse models of lethal R
australis and R conorii infections. We observed that, similar to Doxy, initiating daily treatment with Istra up to 48
hrs post-infection (p.i.) conferred protection against lethality in mice. However, no protection was observed when
Istra or Doxy was administered individually when treatments begin at 72 hrs p.i. We found that treatments
beginning at 72 hrs p.i. using combinations of Doxy and Istra exhibit protection. Mechanistic studies suggest that
the inhibition of A2AR enhances the host's innate immune response, resulting in improved bacterial clearance.
Our central hypothesis is that A2AR signaling dampens anti-R immunity, and targeting A2AR with FDA- or FDA-
Investigational New Drug (IND)-approved drugs may provide a potential avenue for novel therapeutics against
severe R infections. During this multiple-PI project, we will perform a mechanistic study to determine the role of
A2AR in R infection (Aim 1); utilize cost- and effort-effective approaches to identify lead candidates among
FDA/IND-approved A2AR antagonists for therapeutics against R infection using immune signature analyses,
single living cells, ex vivo assays, and prioritization and selection based on the overall drug properties including
absorption, distribution, metabolism, excretion and toxicity (ADMET) profiles from the FDA database (Aim 2)
before moving to in vivo efficacy studies to evaluate the therapeutic efficacy of the optimized lead candidate,
solely or combined with Doxy, for the treatment of lethal rickettsial infection at later timepoints (Aim 3). The
proposed research is based on more than a decade of extensive studies of the cAMP signaling in R infections
immunology, and medicinal chemistry performed in our laboratories and demonstrated in the joint publications
of the MPIs, the co-I, and consultants, and directly builds on a number of ongoing or recently completed clinical
trials targeting A2AR. Success will save huge amounts of time and resources and lead to the identification of a
new class of therapeutics for fatal rickettsiosis and potentially for other bacterial infections given that the reported
evidence suggests deletion of A2AR protects animals from polymicrobial sepsis.

Public health relevance
Project Narrative The bacteria Rickettsia can cause fatal human infections, and our recent research showed that targeting A2AR combined with antibiotic Doxycycline is potentially therapeutic for otherwise lethal rickettsial infections at later times in infection. We propose new animal experiments to repurpose 18 drugs in ongoing or recently completed clinical trials targeting A2AR to identify two FDA-approved A2AR antagonists, one as the lead and the other as a backup for future clinic trial. Success will save vast amounts of time and resources and lead to the identification of a new class of therapeutics for fatal rickettsiosis and potentially for other bacterial infections.